RANDOMIZED STUDY OF THYROXINE TREATMENT OF VERY LOW BIRTH WEIGHT INFANTS

To determine whether giving small daily doses of thyroid hormone will increase survival or decrease chronic lung problems common in small premature babies. The effect of a replacement dose of thyroxine on the pituitary-thyroid axis and clinical outcome of premature infants will be studied using double blind placebo control design.